Duration and Function of Lung Tissue Resident CD8+ Memory T cells

PROJECT SUMMARY/ABSTRACT
Influenza is a respiratory virus that infects an estimated one billion people around the world annually. While there
is an influenza vaccine, it is typically only 40-60% effective and people must receive it every year. Additionally,
the vaccine does not protect against future, and possibly pandemic, strains of influenza and thus there is a major
need for new vaccination strategies. CD8+ T cells can provide cross protection against different strains of
influenza because they recognize internal epitopes that are conserved. Specifically, due to their position in the
lung, CD8+ tissue resident memory T cells (TRM) can rapidly respond to infection and mediate protection by
reducing viral loads and immunopathology. In mice, studies have shown that influenza-specific CD8+ lung TRM
have limited durability, but it is unknown how long lung TRM survive in humans. Additionally, the mechanisms by
which lung TRM cytokines reduce viral loads and immunopathology is unknown in mice, and even less is known
about the function of lung TRM in humans. Here, we propose a series of experiments to fill these critical gaps in
knowledge. In Aim 1, we will use longitudinal bronchoalveolar lavage samples from lung transplant patients and
antibodies specific for mismatched HLA alleles between recipient and donor to track the duration of donor lung
TRM and the development of recipient lung TRM by flow cytometry. Additionally, we will determine the dynamics
of flu-specific human lung TRM by performing immunophenotyping on longitudinal bronchoalveolar lavage, blood,
and nasal lavage samples from lung transplant patients that become infected with influenza. In Aim 2, we will
obtain healthy lungs that are unable to be transplanted in order to examine the effector functions of human lung
TRM. Lung cells will be stimulated with influenza peptide pools to determine the cytokines produced by influenza-
specific lung TRM, and the impact those cytokines have on neighboring cells in the lung tissue. Additionally, we
will then use mice to mechanistically determine the effect of individual lung TRM cytokines to reduce viral loads
and activate neighboring innate cells. Through this proposed work we hope to better understand the role that
human lung TRM play in the immune response to influenza. Lastly, as lung TRM are generated in response to
respiratory viruses, and not just influenza, results of this study could provide insights into the immune system
that could improve vaccine design for all respiratory viruses and aid in the prevention of future global pandemics.

Public health relevance
PROJECT NARRATIVE The influenza vaccine needs to be improved since the current vaccine is only 40-60% effective, must be received annually, and provides limited protection against new, potentially pandemic strains of influenza. CD8+ T cells that reside in the lung can protect against current and potentially emerging strains of influenza and could increase the effectiveness of the flu vaccine. This project aims to improve our understanding of the duration and function of lung CD8+ resident memory cells in humans to determine their potential utility in a vaccine strategy for influenza or other respiratory pathogens.